Project III: Engineering immunogenic cell death in melanoma and renal cell carcinoma.

Project III. Engineering immunogenic cell death in melanoma and renal cell carcinoma
Experimental Lead: Cheng
Computational Lead: Leslie
Experimental Co-Investigator: Li
PROJECT SUMMARY
Recent approval of immune checkpoint blockade (ICB) in multiple cancer types has revolutionized cancer care,
but only a small fraction of patients achieve a durable complete response. Hence, there is an urgent need for
novel immunotherapy-based therapeutic strategies to enhance response and offer long-term survival benefits.
We hypothesize that induction of immunogenic cancer cell death is one of such strategy. Necroptosis and
pyroptosis, two forms of programmed necrosis, are pro-inflammatory and probably immunogenic. By contrast,
mitochondrial apoptosis is generally considered immunologically silent. The BCL-2 family proteins are central
regulators of mitochondrial apoptosis. BAX and BAK, once activated by BH3-only molecules, trigger
mitochondrial outer membrane permeabilization (MOMP), which releases cytochrome c to activate the
apoptosome and caspases. Recent paradigm-shifting discoveries have shown that BAX/BAK activation in the
absence of caspases can trigger the release of mitochondrial DNA to the cytosol through a process called
“mitochondrial inner membrane permeabilization” (MIMP), which activates the cGAS/STING pathway and type I
interferon response. These findings indicate that this form of BAX/BAK-dependent, caspase-independent cell
death, which we termed “mimptosis”, is highly inflammatory. Here, we engineer models of inducible cell death in
murine melanoma and genetically engineered mouse models (GEMMs) of clear cell renal cell carcinoma
(ccRCC) to compare the immune response to apoptosis, mimptosis, pyroptosis, and necroptosis in vivo. Our
goal is to identify the most immunogenic cell death that not only kills cancer cells but also instructs the immune
system to enhance ICB response and elucidate the underlying molecular mechanisms using a comprehensive
systems biology approach. In Aim 1, we will characterize the impact of different kinds of engineered
immunogenic cell death (ICD) on tumor-immune ecosystem dynamics melanoma using integrated single-cell
multiome, paired single-cell RNA and T cell receptor (TCR) sequencing, and multiplexed immunofluorescence.
Computational modeling will define immune cell gene expression and regulatory programs in response to ICD
to inform therapeutic strategies to improve ICB. In Aim 2, we will determine whether and how immunogenic cell
abrogates tumor progression and metastasis and generates immunological memory against tumor rechallenge
in GEMMs of ccRCC. A comprehensive multidimensional assessment and computational modeling of tumor-
immune ecosystem evolution, T cell epigenetic and functional states, and TCR repertoire in response to different
types of cell death will unravel mechanisms that promote anti-tumor immunity. TCGA analysis revealed that low
expression of apoptosome components, APAF1 and Caspase-9, is associated with better survival outcomes,
suggesting that caspase-independent mimptosis may activate anti-tumor immunity and confer survival benefits
in ccRCC. We will assess this hypothesis by performing single-nucleus multiome and MxIF in patient ccRCC
samples to characterize tumor-immune cross-talk comparing ccRCC with low vs high apoptosome expression.